Role of BMP and FGF signaling during limb development

We are studying a neglected area of research on limb development: formation of the girdles that anchor the limbs to the trunk of the body (the scapula for the forelimb and the pelvis for the hindlimb). Using sophisticated genetics and cutting-edge imagery of gene expression we are defining which FGFs are responsible for forming this most proximal element and initiating limb formation (in the case of the pelvis). By comparing three different types of mutants, we have determined that at least 5 FGFs apparently coordinate the development of this structure. We have determined that the primary of FGF signaling in this process is not to ensure cell survival or proliferation, but rather the allocation of limb progenitor cell to the limb bud.